ProMoTr: A Proteomics Center for MoTrPAC

PROJECT SUMMARY
Although the health benefits of physical activity in prevention and mitigation of many chronic diseases have
been documented for decades, the molecular mechanisms mediating these health benefits are still poorly
understood. To understand the adaptive response of physical activity at the molecular level, it is essential to
comprehensively characterize the dynamic changes in protein expression and post-translational modifications
(PTMs) in tissues and circulating biofluids. The overall objective of the PNNL Proteomics Chemical Analysis
Center for MoTrPAC (ProMoTr) is to support the consortium by providing comprehensive discovery and
subsequent targeted verification analyses of circulating protein factors in blood and associated PTMs in
multiple tissue types collected by the Pre-clinical Animal Study Sites and Clinical Centers of MoTrPAC. To
develop a `molecular map' of transducers that provide the impacts of physical activity in humans, the
ProMoTr's integrative proteomics analysis plan has two major foci. First, we will focus on the circulating
secreted factors found in blood plasma and tissues based on the known cross-talk between and within tissues
resulting from physical activity. Second, we will investigate the tissue- and cellular- level response to physical
activity by assessing intracellular signaling as mediated by protein PTMs, including protein phosphorylation,
reversible redox modifications, and lysine acetylation and acylation. The Specific Aims of ProMoTr are: 1) to
provide the Proteomics Chemical Analysis Element to discover and verify circulating factors and intracellular
molecular transducers; 2) to provide the Bioinformatics Element to fully support the needs of ProMoTr in
statistical design, data processing, analysis, interpretation, and dissemination; 3) to provide the Administrative
Element to oversee internal activities and to provide high-level collaborative interactions with MoTrPAC centers
and the broader consortium. The feasibility of performing high quality reproducible discovery and verification
analyses on the scale of tens of thousands of tissue samples is built upon PNNL's record of accomplishment of
large-scale integrative proteomics programs. The PNNL foundation includes refined quality control, large-scale
computation, and dissemination capabilities, our recognized expertise in the development and deployment of
cutting-edge mass spectrometry-based technologies, and our capabilities for studying protein PTMs that are
closely linked with energy metabolism.

Public health relevance
PROJECT NARRATIVE The proposed research aims to provide a comprehensive map of the protein “molecular transducers” that transmit the health benefits of physical activity by applying high throughput proteomics technologies. This project will be accomplished by a team and facility with an excellent record of accomplishment applying and developing advanced mass spectrometry-based workflows and pipelines for proteomics research for human health applications.